Training Program for Antiretroviral Discovery, Evaluation and Application Research (ADEAR)

PROJECT SUMMARY
The Training Program for Antiretroviral Discovery, Evaluation and Application Research (ADEAR) is an
integrative program that provides multidisciplinary training in basic, translational and clinical science in human
immunodeficiency virus type 1 (HIV)/Acquired Immunodeficiency Syndrome (AIDS) research. Postdoctoral
scientist will receive training under the direction of a broadly based group of faculty at the University of
Colorado, Colorado State University and the University of Denver who are who experienced mentors and
actively engaged in research related to the discovery and evaluation of new antiretroviral drugs or the
application of existing antiretrovirals for the treatment and prevention of HIV/AIDS.
This application for T32 grant funding will establish ADEAR as a new research training program that will
provide interactive postdoctoral research training to produce well-rounded laboratory and clinical scientists who
are better able to address the knowledge gaps needed to end the global AIDS epidemic. To foster
multidisciplinary research opportunities for ADEAR trainees, the program has engaged experienced and
productive HIV/AIDS investigators as mentors for trainees. The areas of mentored training available to
trainees include antiretroviral discovery through basic and translational science, clinical evaluation of
antiretrovirals, and application of antiretrovirals in clinical and community settings. The proposed program
includes the following innovative features:
 Thomas Campbell, M.D., an experienced clinical investigator and mentor, and Mamuka Kvaratskhelia,
Ph.D., an experienced basic scientist and mentor will serve as Co-Program Directors.
 Integrated HIV Clinical Investigator and HIV Basic/Translational Scientist pathways within the program
to better meet the training needs of trainees with diverse research backgrounds and career paths.
 A robust plan to facilitate recruitment of trainees both from within the affiliated institutions and from
other institutions outside of Colorado.
 A formal plan to improve the mentoring skills of program faculty.
 Measures to facilitate trainee careers as NIH funded independent investigators including a required
individual Career Development Plan; clearly defined career development “deliverables” including
research publications and requirement of submission of a K award application; and provision of up to 3
years of support to trainees to ensure sufficient time to develop a K application.
 Robust methods for internal and external review of program progress and procedures for adjusting the
training curriculum, if necessary, to better meet the needs of trainees.
The proposed postdoctoral training program will be well equipped to train basic and clinical scientists from
diverse disciplines, prepare them for collaborative research careers, and thereby produce investigators with the
skills needed to fill knowledge gaps in the use of antiretrovirals as tools to end HIV/AIDS.

Public health relevance
PROJECT NARRATIVE The Training Program for Antiretroviral Discovery, Evaluation and Application Research (ADEAR) will provide a rich, dynamic, interactive and supportive environment to train outstanding post-graduate scientists in basic, clinical and translational research that will lead to improved treatment and prevention of HIV/AIDS. This will be accomplished through a collaborative effort between the faculty of the University of Colorado, Colorado State University and the University of Denver. ADEAR will be based at the University of Colorado Anschutz Medical Campus but will take advantage of the diverse research training opportunities available in the affiliated institutions to train the next generation of laboratory and clinical scientists to conduct the research needed to end the AIDS epidemic.